Notch Signaling in Endochondral Bone Development

PROJECT SUMMARY:
A primary function of growth plate cartilage is to support bone formation and elongation during endochondral
ossification. Growth plate chondrocytes undergo rapid proliferation and matrix synthesis followed by hypertrophic
differentiation. Hypertrophic chondrocytes secrete various factors that degrade the cartilage matrix, recruit vascular
cells and osteoblast progenitors, and promote the differentiation of osteoblasts responsible for new bone formation.
Dogma dictates that hypertrophic chondrocytes ultimately undergo apoptosis to facilitate removal of the cartilage
template that is eventual replaced by bone. Recent cartilage-specific lineage tracing studies have suggested that
terminal hypertrophic chondrocytes are capable of directly differentiating into mature osteoblasts during bone
formation and repair via a process known as transdifferentiation. However, our preliminary data suggests that at least
a subset of terminal hypertrophic chondrocytes undergo dedifferentiation to generate bone marrow mesenchymal
stem/progenitor cells (BMSCs) capable of differentiating into various mature cell types including: osteoblasts and
adipocytes. Since almost nothing is known about this process, our long-term goal is to identify the cellular and
molecular mechanism(s) that regulate hypertrophic chondrocyte dedifferentiation during endochondral bone
formation. Using a variety of sophisticated mouse genetic models and in vitro systems, we aim to: (Aim 1) identify
whether hypertrophic chondrocytes dedifferentiate to form a molecularly and functionally distinct population of
multipotent BMSCs, (Aim 2) determine whether NOTCH signaling in hypertrophic chondrocytes is necessary and/or
sufficient to promote chondrocyte dedifferentiation during endochondral bone formation, and (Aim 3) establish whether
SOX2 is an important regulator of hypertrophic chondrocyte dedifferentiation and a target of NOTCH signaling in the
regulation of this process. Completion of these aims will have broad implications in skeletal biology by elucidating
fundamental cellular and molecular mechanisms associated with the novel process of hypertrophic chondrocyte
dedifferentiation during endochondral ossification. This work will also aid our understanding of NOTCH-related skeletal
diseases, as well as, set the stage for developing novel approaches for the ex vivo generation of mesenchymal
stem/progenitors from cartilage for use in regenerative medicine or cell therapeutic applications.

Public health relevance
PROJECT NARRATIVE: Recent cartilage-specific lineage tracing data have challenged the dogma that growth plate chondrocytes solely undergo apoptosis prior to osteoblast cell recruitment and replacement of the cartilage matrix by bone, and instead suggests that hypertrophic chondrocytes alter their cell fate to ultimately become osteoblasts. However, no cellular or molecular mechanism(s) have been proposed to explain this phenomenon. This proposal will demonstrate that some hypertrophic chondrocytes dedifferentiate into bone marrow mesenchymal stem/progenitor cells (BMSCs) prior to further differentiation into the osteoblast or other lineages, while also identifying the roles that NOTCH and SOX2 signaling play in controlling this process during bone development.